Cervical Cancer Moonshot

"There are several challenges to cervical cancer control worldwide that differ in high- and low-resource settings. Areas with ample resources face issues of inefficient screening, overtreatment, and low HPV vaccine uptake in some places. In contrast, areas with limited resources struggle with lack of access to screening tests, unsustainable multi-visit screening programs, limited treatment options, and low access to HPV vaccines.

To overcome these barriers, NCI researchers are addressing four major areas for accelerated cervical cancer control:

Advance understanding of HPV and multi-stage carcinogenesis
Invent and validate novel assays and prevention methods
Unify national and international guidelines and recommendations
Enable global control efforts through integration of screening and vaccination.